Palm Springs Symposia on HIV/AIDS

Project Summary The human immunodeficiency virus (HIV) currently infects more than 1million Americans. The Palm Springs HIV/AIDS Symposium brings together experts from all across the United States to discuss their research to better understand how HIV causes the acquired immune deficiency syndrome (AIDS) and ultimately, death. This meeting greatly improves our likelihood of eliminating AIDS from North America and globally.

Public health relevance
Public Health Relevance Globally, millions of people are infected with the AIDS virus, and while there are medications that can minimize viral replication, as yet there is no cure or effective vaccine for HIV infection. Scientific meetings, where new data and information can be freely exchanged, can help speed progress towards the goal of eradication of HIV disease. The Palm Springs Symposia on HIV/AIDS are intimate meetings where experts in the field present data and interact with attendees on a wide range of AIDS-related topics with the goal of eliminating the AIDS epidemic.